Society for Research on Nicotine & Tobacco 2025 Annual Meeting

PROJECT SUMMARY
The Society for Research on Nicotine and Tobacco (SRNT) is the only international scientific society
dedicated exclusively to the field of nicotine and tobacco research. SRNT has more than 1,200
members from over 40 countries, with approximately 85 percent of those members being affiliated
with U.S. academic, research, government, advocacy, and related organizations. The overall
objective of the SRNT Annual Meeting is to stimulate advancement in the field of nicotine and
tobacco research through the presentation of timely and cutting-edge research, discussion, and
networking. It is the hallmark conference in the field where investigators, advocates, and
policymakers can learn about the latest scientific findings, including novel products in the marketplace
and effective interventions and policies to reduce tobacco use in the U.S. and in other countries. The
SRNT Annual Meeting provides a crucial venue for the presentation of the rapidly evolving tobacco
regulatory science research findings to the major keyholders in research and policy.
The aims of this conference grant are to: 1) ensure that tobacco regulatory science content is
presented in ways that are maximally informative to FDA and to researchers in the field; and 2) to
support the career of trainees and early career investigators in tobacco regulatory science via
opportunities for special oral sessions, professional development forums, travel awards, and other
recognition.
To meet both aims, SRNT’s Program Committee meets regularly throughout the year to plan the
content and format of the SRNT 2025 Annual Meeting, aligning the presentation of scientific content
with research priorities in the Tobacco Regulatory Science Program (TRSP). The Committee will
curate paper sessions on specific topics that highlight advances in the area, foster scientific
discussion and debate, and stimulate collaboration across researchers. The conference grant will
also support at least 10 travel awards for trainees and early career investigators presenting on
content related to the FDA and NIH Tobacco Regulatory Science Program research priorities. These
interactions will facilitate the development of novel questions and approaches to tobacco regulatory
science research and support the careers of future researchers in tobacco regulatory science.

Public health relevance
PROJECT NARRATIVE According to the Center for Tobacco Products, “ FDA supports science and research to help us better understand tobacco use and associated risks so that we can reduce the public health burden of tobacco in the United States. Research programs and projects include, but are not limited to, the scientific fields of epidemiology, behavior, biology, medicine, economics, chemistry, engineering, toxicology, pharmacology, addiction, public health, communications, marketing, and statistics.” SRNT's mission is “to stimulate the generation and dissemination of new knowledge concerning nicotine in all its manifestations, from cellular to societal.” CTP and SRNT clearly share a commitment to science and research. The primary venue for presenting the latest, cutting-edge research on all things nicotine related is the SRNT Annual Meeting, which in 2025, will be held in New Orleans. SRNT anticipates attendance of at least 1,200 researchers with five plenary lectures; six Podium Session across three days, each with 10 concurrent breakout sessions—each of which has at least five presenters—for a total of 300 or more oral presentations of science. In addition, the SRNT 2025 Annual Meeting will feature five poster sessions, each with at least 150 scientific posters/presenters—for a total of at least 750 poster presentations. The SRNT Annual Meeting is an optimal venue for the presentation of novel findings from tobacco regulatory science research projects and networking across scientists in this emerging field. The aims of this conference grant are to: 1) ensure that tobacco regulatory science content is presented in ways that are maximally informative to FDA and to researchers in the field; and 2) to highlight the work of trainees and early career investigators in tobacco regulatory science via special oral sessions, professional development forums, travel awards, and other recognition. The majority of presenters and attendees are from US-based academic institutions. However, conference attendees also include researchers from Europe, Oceania, Latin America, Africa, and Asia. Tobacco Regulatory Science is growing in importance around the globe and the 2025 Annual Meeting—the largest scientific conference to focus on nicotine and tobacco research anywhere in the world--will provide an outstanding opportunity not only for the presentation of research in this area, it will facilitate networking/interaction among tobacco regulatory researchers across global geographic regions.